Mechanisms of vitamin A deprivation and replacement therapy

Project Summary/Abstract
Vitamin A is critical for human health and vision. Insufficient uptake of vitamin A severely damages
photoreceptors, causes a loss of visual pigments, and is the leading cause of preventable
childhood blindness according to the WHO. However, little is known about how vitamin A
deprivation affects photoreceptors on the molecular level and how vitamin A replacement therapy
mediates structural and functional photoreceptor recovery. Our long-term goal is to use the
Drosophila melanogaster retina as a model to fill this gap in our knowledge and to analyze the
underlying mechanisms.
This proposal synergistically combines Drosophila genetics, immunohistochemistry, behavioral
analysis, and quantitative proteomics. This multidisciplinary approach will allow us to evaluate the
central hypotheses that different photoreceptor types – functionally equivalent to human rods
and cones - respond differently to vitamin A deprivation and that vitamin A deficiency triggers
protective mechanisms that stabilize damaged photoreceptors. We will pursue three major
specific aims. First, we will analyze how different photoreceptor types respond to vitamin A
deprivation. Second, we seek to identify the proteins and cellular pathways that are affected by
vitamin A deprivation and vitamin A replacement therapy. Third, we will determine the function of
a novel transmembrane protein that we found to be highly upregulated in vitamin A-deprived
retinas to stabilize the damaged photoreceptors.
The proposed research is significant, as it will provide fundamental insights into the molecular
response of different photoreceptor types to vitamin A deprivation. It will also unravel how vitamin
A replacement therapy leads to improvement of photoreceptor structure and function. Collectively,
this proposal has the potential to identify mechanisms that stabilize damaged photoreceptors and
to open new avenues for treating human eye diseases.

Public health relevance
Project narrative Vitamin A is critical for human vision and according to the World Health Organization, vitamin A deficiency is the leading cause for preventable childhood blindness. The proposed research uses Drosophila melanogaster as a model to analyze how different photoreceptor types are affected by vitamin A deprivation and how they recover upon vitamin A replacement therapy. This proposal has the potential to discover novel molecular mechanisms that promote photoreceptor survival and thus could serve to treat human eye diseases.